Engineering dendritic cells to target islet antigen to pro-tolerogenic subsets for prevention and treatment of Type 1 Diabetes

Project Summary
Although induction of antigen-specific tolerance by means of targeting such antigens to dendritic cells (DCs) has
been reported in multiple pre-clinical studies, there are currently no effective approaches using DCs in the clinic
to prevent or reverse autoimmunity. DCs have been proven to intrinsically possess the ability to restore and
maintain immune tolerance, making them very attractive candidates for treatment of autoimmune diseases.
However, only non-activated DCs (which inherently possess a tolerogenic/suppressive phenotype) can induce
tolerance, whereas activated DCs can trigger immunity. Notably, there is no strategy able to deliver antigen
uniquely to non-activated DCs. To overcome this limitation, the long-term goal of this proposal is to engineer
DCs to guarantee presentation of islet-derived antigen solely by tolerogenic subsets to treat Type 1 Diabetes
(T1D). The central hypothesis is that by ensuring that islet-derived antigen is presented exclusively by tolerogenic
DCs, these DCs will lead to elimination of islet-specific auto-reactive T cells and induction of protective Tregs.
The overarching goal of this proposal will be tested by pursuing the following two specific aims: (1) Engineering
DCs to express islet-derived antigen using circuits that limit expression to pro-tolerogenic DCs and (2)
Engineering DCs to artificially enforce a pro-tolerogenic irreversible phenotype while also driving expression of
islet-derived antigen. For Aim 1, constructs containing a new promoter driving expression to tolerogenic DCs in
combination with microRNA-based circuits that prevent antigen expression in response to inflammation will be
tested for induction of tolerance. For Aim 2, a transcription factor that can enforce DCs into a highly pro-
tolerogenic state will be used in a construct encoding islet-derived antigen to engineer DCs in T1D mouse
models. This transcriptional regulator was identified in intra-tumor DCs, and its enforced activation was found to
shape DCs into an immune suppressive state that could not be reverted even in response to strong inflammatory
stimuli. The proposed research is innovative because it attempts for the first time to engineer DCs to ensure
presentation of islet-derived antigen only by pro-tolerogenic cells. The significance of this proposal is that, if
successful, it will have identified a strategy to safely engineer DCs for induction of tolerance and will provide a
strong scientific framework for further investigations to engineer these critical orchestrators of the immune
system. Ultimately, the knowledge derived from this work has the potential to lay the ground for innovative
engineering-based therapies to stop autoimmunity in T1D, which constitutes an essential step to achieve a cure.

Public health relevance
Project Narrative The proposed research is aimed at developing strategies to engineer dendritic cells so they can be safely used for induction of antigen-specific tolerance in type 1 diabetes. This work is relevant to public health and the NIH’s mission because these approaches hold the potential to prevent and to help achieve a cure for this disease.